Antigen-specific radiosensitization

PROJECT SUMMARY/ABSTRACT:
A total of 13 antibody drug conjugates (ADCs) are now FDA approved, including several in solid tumors. In this
application, we propose that the ADC format can deliver potent radiosensitizers that are specifically targeted to
antigen-bearing tumor cells with relative sparing of normal tissue and thereby improve the therapeutic index of
radiosensitizion. We have developed first-in-class ADCs and payloads that are specifically designed for
combination with external beam radiotherapy. The first molecules are HER2-directed ADCs containing DNA
damage response inhibitors as payloads and have demonstrated efficacy in vitro and in vivo with potencies
competitive with clinically relevant benchmarks. Other HER2-directed ADCs have established clinical efficacy
in breast adenocarcinomas, non-small cell lung cancers, colorectal cancers, and gastroesophageal/gastric
cancers. In one version, the payload is a small molecule inhibitor of the ATM kinase, which is a sensor of
double strand breaks and activates DNA damage-induced cell cycle checkpoints, phosphorylates key double
strand break repair genes, and provides resistance to radiotherapy and other DNA damaging agents. In a
second and parallel effort we have developed the most potent known inhibitor of the nonhomologous end-
joining factor Ligase IV (LIG4) with efficacy at 10nM. Our design employs small double stranded DNA oligos
with a strategically placed E3 ubiquitin ligase ligand pomalidolide to induced ubiquitination and degradation of
LIG4. This LIG4 degrader (NHEJ-P) is highly radiosensitizing and ideal for conjugation as an antibody-oligo-
conjugate, which have also emerged clinically. In this proposal, we seek to further develop these lead ADC and
AOC molecules in three independent specific aims. In SA1, we will further develop the in vivo activity of the
trastuzumab-ATMi ADC (named t-ATMi) in terms of the onset and duration of ATM inhibition and test in
additional xenograft models commonly used anti-HER ADC development. In SA2, we will perform lead
optimization of our LIG4 degrader payload (NHEJ-P), evaluate its mechanism of action, and test antibody-
oligo-conjugate formulations in vitro and in vivo. In SA3, we will pursue thorough investigations into possible
overlapping toxicities between ADC/AOCs and radiation including both on-target/off-tumor and off-target
toxicities from the side of the ADC/AOC and acute, subacute, and late radiation toxicities to the skin, liver,
kidney bowel, lung, and heart, respectively. We have assembled a team with broad expertise in medicinal
chemistry, DNA repair, ADC development, and radiation toxicity modeling in mice to support each aim and
subaim. The net result of this project will be to de-risk and refine radiosensitizing ADC and AOCs ahead of
clinical translation. The impact of this project may extend beyond HER2+ malignancies and even beyond
radiotherapy, since an effectively linker-payload could be conjugated to other clinically active antibodies and
combined with other DNA damaging systemic therapies.

Public health relevance
PROJECT NARRATIVE: Therapeutic radiation remains a mainstay of cancer treatment, but in many circumstances, it is limited in efficacy due to side effects from its effect on normal tissues. We have discovered novel antibody drug conjugates and inhibitors of DNA repair which we can specifically impair cancer’s ability to repair DNA damage without affecting normal cells. We hope these therapeutics will improve public health by improving the efficacy of radiation therapy in cancer treatment.